Development of Gene Replacement Therapy for Sanfilippo Syndrome Type C

PROJECT SUMMARY/ABSTRACT
Lysosomal storage diseases (LSD) are rare inherited metabolic disorders caused by defects in the cellular
catabolic system. Mucopolysaccharidosis Type IIIC (MPS IIIC or Sanfilippo disease type C) is one such LSD
that is caused by deficiency of the enzyme heparan sulfate acetyl CoA: -glucosaminide N-acetyltransferase,
(HGSNAT) essential for degradation of heparan sulfate, a repeating carbohydrate generally found attached to
proteoglycans. This disease causes accumulation of heparan sulfate resulting in a progressive and severe
neurological deterioration early in life with little somatic features. The symptoms in patients with MPS IIIC may
present at an average age of 3.5 years of age with psychomotor developmental delays and behavioral problems.
Before the age of 15 years verbal communication is often lost in patients with MPS IIIC. Most lose the ability to
walk between the 20 and 30 years of age. The condition is fatal by an average age of 34 years (range, 25-48).
Enzyme replacement therapies are not an option since the protein is localized and bound to lysosomal
membrane. There are currently no treatments available for treatment of MPS IIIC. Individuals affected by
MPS IIIC are managed with supportive care, consultation with medical professionals from multiple disciplines,
physical therapy, and pharmacological interventions to alleviate symptoms. Gene therapy represents a
reasonable and promising approach to provide a meaningful and long-term therapeutic benefit for this population
in the near future.
The goal of this SBIR project is to complete tissue level assessments in the disease model, scale up
manufacturing and establish safety on a GLP regulated study in rats. These activities will help build a robust
briefing package for IND-filing for our gene therapy product, JLK-247. The progress will help us navigate the
“valley of death” by establishing milestones and making go/no-go decisions. The safe therapeutic dose-range
established will help us extrapolate and translate therapeutic doses to clinical phase I trials.
This proposal leverages the scientific expertise in gene therapy preclinical development and regulatory
experience of Srikanth Singamsetty, PhD (Phoenix Nest, Inc.) for the product development. Jill Wood, BS
(Phoenix Nest, Inc.), will manage the project finances and personnel responsible. Professor Steven Gray, PhD
(The University of Texas Southwestern Medical Center, Dallas, TX) is our gene therapy subject matter expert.
Successful completion of this project will help with initiating clinical trial dosing, a first step towards a long-term
therapy for MPSIIC, a dreadful and fatal pediatric disease.

Public health relevance
PROJECT NARRATIVE Our project is focused on development of a new treatment for Sanfilippo Syndrome Type C, a fatal neurodegenerative disorder of childhood, which has enormous health and socioeconomic impact on many families and on the healthcare system. We will execute pivotal nonclinical studies and manufacturing goals set by FDA/CBER that are required for IND approval to initiate JLK-247 gene therapy clinical trials. We intend to develop and commercialize the first specific therapy for this indication.